Defining Epigenetic Regulation of Translational and Post-Translational Modification Signaling in Aortic Valve Stenosis via Multi-Omics Approaches

Project Summary/Abstract
Calcific Aortic Valve Disease (CAVD) will affect 3% of people over the age of 75. CAVD disease
progression is characterized by an active deposition of calcific noduli and extracellular matrix proteins. This
excessive deposition results in valvular thickening, outflow tract narrowing, restricted blood flow, left ventricular
hypertrophy, and eventual heart failure. Despite the clinical significance of this disease, patients must “watch
and wait” until surgical AV replacement and repair is necessary, as currently no pharmacotherapeutics exist.
This proposal focuses on identifying novel epigenetic mechanisms underlying calcific aortic valve disease
progress and pathophysiology. For preliminary investigation on the role of epigenomic regulators in valve
calcification, we re-mined proteomic datasets to specifically probe differential abundance of epigenetic factors –
that is, proteins involved in histone post-translational modification reading, writing, and erasing. The preliminary
data presented in this proposal shows that enzymes responsible for histone regulation are differentially abundant
in valvular tissue as a function of disease stage, structural localization within the valve leaflet, as well as within
VIC cultures as a function of calcification induction media (inorganic vs. organic phosphate media). However,
the dataset mined was not exhaustive in identification as it was untargeted. Additionally, our preliminary data did
not investigate the regulatory role epigenetics plays in downstream translational and post-translational signaling
required for cell-cell, cell-matrix, and cell-vesicle mediated signaling. The proposed research capitalizes on an
ever-expanding cohort of clinically defined human adult CAVD aortic valve tissue, as well as an extensive
biobank of valvular interstitial cells isolated from human donors. It is our central hypothesis that there are unique
histone modifications that contribute to pathological development of calcification in human aortic valves. Aim 1
will use novel mass spectrometry approaches to define the histone code of CAVD along with corresponding
transcriptional regulation via Chromatin Immunoprecipitation sequencing. Aim 2 will determine cell-mediated
spatially localized translational targets downstream of epigenetic regulation, utilizing multi-modal
histopathological imaging, laser capture microdissection, and low-input proteomic strategies. Aim 3 will
investigate the role of epigenomic modifications on microenvironment signaling mediated by N-linked
glycosylation. By mapping the histone code of aortic valve calcification and identifying both upstream epigenetic
regulators and downstream transcriptional, translational, and post-translational targets of this epigenetic
regulation, we aim to identify potential pharmacotherapeutic targets that may halt progression of CAVD. These
studies will be conducted by Dr. Clift under the mentorship of Dr. Elena Aikawa, a pioneer in cardiovascular
systems biology, as well as an advisory committee dedicated to proposed research and trainee. By utilizing this
mentorship and professional development via the MOSAIC UE5, Dr. Clift is primed for successful independence.

Public health relevance
Project Narrative Calcific Aortic Valve Disease (CAVD) is a significant clinical burden that can only be treated via surgical repair or replacement. Our aim for this proposal is to elucidate the molecular mechanisms behind the rapid extracellular matrix dysregulation and calcification deposition leading to valvular thickening and heart failure in human CAVD samples via multi-omic approaches with the hope of identifying pharmacotherapeutic targets. We aim to change the paradigm of treatment from “watch-and-wait” surgical replacement to biomarker identification and early intervention with antifibrotics and anticalcific treatment targeted to specific modifications of histone subtyes, to halt disease progression.